Support services for the Tobacco Harm Reduction Network

This contract provides support services for the Tobacco Harm Reduction Network managed by the Tobacco Control Research Branch located within the NCI Division of Cancer Control and Population Sciences.